Understanding Immune Evasion by HIV-1 Repliclones

Project Summary:
Despite the efficacy and clinical benefits of effective ART, a reservoir of cells harboring replication-competent
(intact) proviruses usually leads to viral rebound within weeks of stopping ART. Although this HIV reservoir is
generally considered to be latent, sensitive PCR-based single copy HIV RNA assays have revealed low-level
viremia in individuals on ART, indicating that latency is not absolute. Several groups including ours have shown
that the HIV reservoir is maintained by the proliferation of infected cells carrying replication-competent (intact)
proviruses (termed repliclones). Previously we reported that low-level persistent viremia on ART can originate
from large clones carrying intact proviruses (Simonetti, et al. PNAS 2016; Halvas, et al. J Clin Invest 2020). This
important finding raises the question of how repliclones escape immune clearance mechanisms despite proviral
expression as evidenced by virion production and viremia. We postulate that one or more possible mechanisms
may be involved that will be investigated in three Specific Aims of the current proposal. These mechanisms
include: i) transcriptional silence (latency) of most proviruses in a repliclone; ii) dysfunctional immune responses
that fail to mediate repliclone killing; iii) mutated proviruses in repliclones that escape CTL or antibody-mediated
effector functions; and iv) intrinsic resistance of the repliclone cells to CD8+ T-cell- and/or NK cell-mediated
killing. In Aim 1, we will characterize repliclones in 10-15 donors on effective ART (Aim 1A), and then quantify
the fraction of proviruses in each clone that are expressing unspliced and single spliced (env) HIV mRNA by our
recently reported cell-associated HIV RNA and DNA single genome sequencing method (Aim 1B). In Aim 2, we
will evaluate three possible mechanisms by which transcriptionally active repliclones evade clearance by CD8+
T-cells. These evaluations will include: i) assessing epitope escape of repliclone proviruses (Aim 2A.1), ii)
evaluating ex vivo cytotoxic activity of autologous T-cell responses with confirmed ability to recognize cells
infected with repliclone virus (Aim 2A.2) and iii) directly determining whether cells comprising repliclones are
inherently resistant to CD8+ T-cell-mediated killing (Aim 2B). In Aim 3, we will evaluate the neutralization
sensitivity of viruses from individual repliclones to autologous and broadly-neutralizing monoclonal antibodies
(Aim 3A), and the killing of repliclones by antibody-dependent cellular cytotoxic (ADCC) (Aim 3B). We will
leverage a suite of novel tools already developed to detect repliclones, examine proviral expression in single
repliclone cells, detect humoral and cellular immune escape variants, and assess the sensitivity of repliclones to
killing by autologous virus-specific CD8+ T-cell clones or by ADCC. The work will be carried out by an ongoing,
productive, and complementary collaboration between the Halvas and Mellors virology laboratories at the
University of Pittsburgh and the Jones immunology laboratory at Weill Cornell Medicine. Insights gained from
this work will be broadly applicable to developing therapeutic approaches for eliminating the persistent, clonally
expanded HIV reservoir, the main barrier to curing HIV infection.

Public health relevance
Narrative HIV persists on antiretroviral therapy (ART) in clonally expanded CD4 T-cells carrying replication- competent proviruses (termed repliclones), which are capable of producing infectious virus and viremia that is not suppressible with ART. The mechanisms involved in clonal outgrowth, persistence and escape from immune-mediated clearance are not defined. Accordingly, we will investigate the mechanisms of clonal persistence including latency, viral escape mutations to antibodies and cytotoxic T-lymphocytes, and intrinsic clonal resistance to immune-mediated killing, in an effort to gain insight on designing strategies that eliminate repliclones and accelerate progress towards a cure for HIV infection.